Genetic Bone Disorders-Autosomal Recessive OI

In an integrated program of laboratory and clinical investigation, we study the molecular biology of the heritable connective tissue disorders osteogenesis imperfecta (OI) and Ehlers-Danlos syndrome (EDS). Our objective is to elucidate the mechanisms by which the primary gene defect causes skeletal fragility and other connective tissue symptoms and then apply the knowledge gained from our studies to the treatment of children with these conditions. <br;br>Structural defects of the heterotrimeric type I collagen molecule are well known to cause the dominant bone disorder osteogenesis imperfecta. A severe recessive form of OI was first postulated in 1979. More recently, investigators have noted that some patients with clinical OI do not have defects detected in the type I collagen genes during sequencing. These patients without mutations in collagen can be divided into those who have abnormal collagen biochemistry and those with normal electrophoretic migration of the collagen chains. We hypothesized that the cause of recessive OI with abnormal collagen biochemistry and normal collagen gene sequence would involve a gene(s) whose products interacted with type I collagen. Two years ago the BEMB identified defects in two components of the collagen prolyl 3-hydroxylation complex, CRTAP and P3H1 (encoded by LEPRE1) as the cause of recessive OI. Our work has generated a new paradigm for collagen-related disorders of matrix, in which structural defects in collagen cause dominant OI, while defects in the components of a complex in the endoplasmic reticulum that modifies collagen cause recessive OI. In the expanded nosology for OI, defects in CRTAP and LEPRE1 are designated as types VII (OMIM #610682) and VIII (OMIM #610915) OI, respectively. Recessive OI is now a major area of investigation for the BEMB. The phenotypes of types VII and VIII OI are distinct from classical dominant OI, but difficult to distinguish from each other. Both groups of children have severe/lethal OI with white sclerae, normal or small head circumference, rhizomelia, metacarpal shortening and severe undertubulation of long bones. Biochemically, both groups have normal collagen sequences with absence of 3-hydroxylation of the Pro986 residue, but full overmodification of the helical prolines and lysines by prolyl 4-hydroxylase and lysly hydroxylase. This overmodification of the helix was unexpected and indicates that absence of the components of the 3-hydroxylation complex leads to delayed folding of the collagen helix. We have now shown that the basis of the phenotypic and collagen biochemical similarity of types VII and VIII OI is that CRTAP and P3H1 are mutually protectively in the complex. We observed that CRTAP is severely reduced and P3H1 is absent from cell lysates which have a defect in either component of the complex, although the transcript level of the normal component is not reduced. The interpretation of mutual protection of CRTAP and P3H1 is supported by immunofluorescence microscopy;reduced levels of both proteins are detected in cells with a mutation in either gene. Mutual protection of components is also supported by the results of stable transfection of CRTAP expression constructs into transformed CRTAP-null cells. Expression of CRTAP restores P3H1, as well as CRTAP protein in these cells. Furthermore, there is a partial rescue of collagen modification in the stably transfected cells, which indicates that the components are functioning to restore collagen folding. P3H1 is partially rescued in CRTAP-null cells treated with inhibitors. Also, in LEPRE1-null cells, the secretion of CRTAP into conditioned media is double the 12% secreted by normal cells.
Among our LEPRE1-deficient patients, we identified a common mutant allele, IVS5+1G to T, which occurred in both African-Americans and West African families which had emigrated to the Washington, DC area. This so-called "West-African allele" accounts for a third of the known LEPRE1 mutations, and has been found only in individuals of African descent. We hypothesized that this mutation had been transported to the Americas via the Atlantic slave trade. To determine the incidence of carriers for this mutation, we developed a restriction digestion assay and a rapid allele-specific genomic SNP assay. We obtained samples from 3 African-American cohorts and identified mutation carriers in 5/995, 5/1429 and 2/631 African-American newborns from Washington,DC, Pennsylvania and Maryland, respectively. This yields a carrier frequency in Mid-Atlantic USA of 1 in 200-300 African-Americans, typical for a rare recessive disorder. In a collaboration with Charles Rotimi of NHGRI we examined over 1200 DNA samples from contemporary Ghanians and Nigerians. To our surprise, this groups had a carrier frequency for this lethal recessive mutation of 1.5%! This high frequency eliminates any concern about a mutation bottleneck occurring during the slave trade, since on a random basis over 300 carriers would have been transported to the Americas. This high carrier frequency also makes the inheritance o severe OI in Africa distinct from the dominant form prevalent in North America and Europe, where recessive OI occurs in 5-7% of OI cases. In West Africa, recessive OI is expected to account for about half of all severe OI. To determine the age of the mutation, we have conduction haplotype analysis on African and North American pedigrees, yielding a 4.2 MB conserved region surrounding the LEPRE1 gene. When the rate of recombination in this region of the chromosome is taken into account the mutation is calculated to be about 600 years old, consistent with a founder mutation in West African that originated before the Atlantic slave trade. We are now conducting studies to determine the geographic distribution of the mutation, whether it is limited to Ghana/Nigeria or is pan-African.